Training Program in Computational Genomics

Project Summary
University of Pennsylvania has trained computational genomicists for the past 20 years supported by
the NHGRI T32 program, training 52 predoctoral and 13 postdoctoral trainees the majority of whom
have gone on to careers in research and development. Here we propose to continue our Computational
Genomic Training program with eight predoctoral and two postdoctoral trainees focused on the theme
of Data Science and Machine/Statistical Learning methods as applied to genomics data. Our training
program concentrates on a rigorous course-based curriculum supported by courses in multiple
graduate groups. In addition, our training also involves 13-16 hours of Responsible Conduct of
Research (RCR) and Scientific Rigor and Reproducibility (SRR) training, Individual Development Plan,
and utilization of Electronic Notebooks and code repositories. Research training is enhanced by a dual
mentorship model whenever possible. Our program is supported by a greater genomics training
program consisting of three NHGRI T32 programs in Computational Genomics (this program), Genomic
Medicine, and ELSI, as well as a NHGRI R25 Diversity Action Plan (DAP). In particular, the DAP
program recruits URM undergraduate and postbacc trainees focused on the Greater Philadelphia Area
whose many institutions serve the urban URM population. This vertical regional integration will allow us
to develop a regional pipeline of URM students with undergraduate research experience in genomics.
Our program consists of 31 trainers of which 14 are female scientists and 2 are URM scientists. Twenty
one of our 31 trainers have an active computational genomics research program. The expertise of the
trainers span disease genomics, genomic technologies, multidimensional statistics, algorithms, data
sciences, and machine learning. Our training environment is enhanced by key facilities including large
biobanks, high-throughput genomics core, high-performance computing core, and a unique immersive
data visualization facility. Penn overall hosts more than 60 NIH training programs with strong
institutional administrative support for managing the training programs including an Office of Biomedical
Postdoctoral Programs, Office of Diversity and Inclusion, combined Biomedical Graduate Studies,
among others. Success of our training program will help train the next generation of genomic workforce
in the skills and knowledge necessary to apply state-of-art computational techniques to genomics and
develop new techniques for novel genomic data.

Public health relevance
Project Narrative This project is to create a training program for graduate students and post-graduate students as well as MD/PHD students to acquire skills to apply Data Science and Artificial Intelligence techniques to genomics of human diseases. Success of the program will contribute to training the next generation of biomedical workforce in the application of state-of-art computation to genomics data.